Effects of COX-1 or COX-2 Deficiency on Mouse Skin Cancer

Primary wild type and COX-2-/- keraticytes were transfected with a retrovirus containing v-H-ras and the transfected keratinocytes grafted on to the backs of athymic nude mice. Tumor incidence and tumor size resulting from transfected COX-2 -/- keratinocytes was markedly reduced compared to tumors produced by transfected wild type keratinocytes. Lower proliferation rates and higher levels of terminal differentiation were observed in the COX-2 -/- keratinocytes compared to wild type keratinocytes. The extent of vascularization and the levels of apoptosis were similar in wild type and COX-2-/- tumors, indicating that neither was not a factor in reducing COX-2-/- tumor size. While the levels of Ras were similar in wild type and COX-2-/- tumor cells, the levels of p-EGFR and p-ERK1/2 were lower in COX-2-/- keratinocytes/tumors compared to wild type keratinocytes/tumors indicating that COX-2 deficiency decreased growth promoting signaling pathways. Thus, the deficiency of COX-2 in the transformed keratinocyte itself was sufficient to decrease tumor growth independent of systemic COX-2 expression.